SBIR Phase I- Topic 410 - Cancer Clinical Trials Recruitment and Retention Tools for Participant Engagement.

Many clinical trials fail to meet their accrual and retention goals, which leads to delays, early termination, or inability to draw conclusions at trial completion due to loss of statistical power. NCI wants to enhance clinical trials recruitment and retention by developing tools that could enhance communication between participants and study staff. In this Phase 1 tool development application we address the NCI interest in simplified informed consent documents that enhance personal communication during the informed consent process. In this Phase I proposal we leverage natural language processing technology and our teams prior work on the Informed Consent Ontology (ICO) to improve the language in consent documents related specifically to permissions granted by a research participant.